The function of H3K23me3, a transgenerationally inherited heterochromatin mark

PROJECT SUMMARY:
H3K23 methylation is an evolutionarily conserved but understudied heterochromatic histone modification
whose function is unknown. In the past year our lab used C. elegans to study H3K23 methylation and found
that it plays a role in nuclear RNAi. Nuclear RNAi is an evolutionarily conserved pathway in which small
interfering RNAs (siRNAs) guide chromatin modifications and transcriptional repression. It protects the host
genome by epigenetically silencing transposons and other “non-self” DNA. We have made the following
discoveries: (1) H3K23me3 is induced by nuclear RNAi and is inherited for four generations. (2) The histone
methyltransferase SET-32, methylates H3K23 in vitro. (3) Both set-32 and the nuclear RNAi effector protein,
hrde-1, are required for nuclear RNAi-induced H3K23me3 in vivo. These discoveries have raised new
questions. What are the other histone methyltransferases responsible for H3K23me3? What is the function of
H3K23me3? Could H3K23me3 contribute to transcriptional silencing in nuclear RNAi? In this proposal I will
take genetic, biochemical, and computational approaches to address these questions in the following aims. (1)
Biochemically characterize and identify the histone methyltransferase(s) responsible for this modification. (2)
Create a functional knockout of H3K23me3 using a dominant negative mutation first discovered in cancer. (3)
Study the function of H3K23me3 in nuclear RNAi. The proposed studies, which explore a fundamental yet
unmapped territory of modern biology, will advance our understanding of the histone code, histone
methyltransferases, oncogenic histones, RNA-mediated transcriptional silencing, and RNA-chromatin
interaction, which are all relevant to human development and disease.

Public health relevance
The function of H3K23me3, a transgenerationally inherited heterochromatin mark Project Narrative: Histone modifications are key epigenetic players that function in transcriptional regulation and chromatin structure. Through these mechanisms, histone modifications are involved in development, gene regulation, aging and several diseases such as cancer, but there are many epigenetic marks that have not been characterized. Using C. elegans as a model organism, I will investigate the function of an understudied but abundant histone modification, H3K23me by identifying its histone methyltransferases and leveraging an oncogenic histone model to create the first knockout model for this mark.